Health Professional Rapid Personalized Learning Platform for Genomic Medicine

Summary Enhancing health providers’ knowledge of genomic medicine is essential to the appropriate use and application of genomic testing and related interventions to support disease prevention, early diagnosis, and improved health outcomes. Several studies have demonstrated the limited knowledge of genomic medicine in a wide range of health providers. Furthermore, there is limited access to and/or numbers of medical geneticists and genetic counselors for consultation or referrals. Genomic medicine is (or will soon be) relevant to all clinical specialties and require educational resources to promote rapid-based learning. As it is clear there is no one size fits all to meet the needs of general and clinical specialists as well as different members of the health care team, we aim to develop a program that can be tailored to individual learning needs. Thus, we propose to develop a Rapid Personalized Learning Platform for Genomic Medicine to promote knowledge about the science and enable the practice of genomic medicine. Distance-based learning programs have become an increasingly popular approach that is convenient to busy health professionals and widely accessible. We will leverage our existing resources from the T32 post-doctoral training program in genomic medicine, particularly our mentors as content specialists, to develop a suite of short online modules that are designed to be free- standing, but can also be combined to develop a comprehensive learning program for a range of health providers. As the field of genomic medicine continues to rapidly develop, these short modules can be updated as needed with limited disruption to learners and to the module developers. Continuing education credits will be provided through Duke University for physicians, pharmacists, physician assistants, and nurses. This proposal will fully support the development and assessment of these online learning modules in genomic medicine, which will serve as the foundation of a Certificate Program in Genomic Medicine. We have institutional support for this certificate program and are excited to have the opportunity to lead in this field.

Public health relevance
PUBLIC HEALTH RELEVANCE The purpose of this grant is to develop a suite of online educational modules that will enable health providers to tailor their educational needs in genomic medicine for their area of practice and role on the health care team. These online modules will be widely available and continuing education credits provided through Duke University.